50th Anniversary Year: Miami Pediatric Nephrology SeminarSustaining the Specialty: Honoring the Past & Promoting the Future

The Miami Pediatric Nephrology Seminar is entering its 50th anniversary year as a sustaining
landmark conference for the sub-specialty of Pediatric Nephrology as well as its many affiliates.
It will be held March 15-17, 2024, in Miami Beach, Florida. The seminar is seen as a unique
opportunity for pediatric and adult nephrologists, renal pathologists, neonatologists, pediatric
urologists, transplant surgeons, nurses, nutritionists, and allied health professionals from all over
the United States and the world. It is known as a contributing factor in sustaining the specialty for
trainees throughout their careers. Topics covered relate to research advances and understanding
of mechanisms of renal disease, glomerulonephritis, hypertension, genetic advances in diagnosis
and management of kidney disease, neonatal nephrology, transplantation, clinicopathologic
correlations, continuous renal replacement therapies and apheresis. There will be a young
investigator’s showcase in which trainees and junior faculty will present their research work in oral
presentations and in poster format. Selection of topics, faculty and format are based on
suggestions from past seminar participants and current questions. This seminar will be in-person
live format with the provision for some special sessions to be available through remote virtual
attendance. The seminar will feature a cadre of distinguished invited Guest Faculty and Local
Faculty as well as sponsored physicians-in-training and early career faculty who will provide
expertise and cordial exchanges in scientific presentations and panel discussions. Funds
requested through the R-13 mechanism will be used to provide registration and travel support for
20 young trainees and 10 junior faculty from within programs in the USA. Throughout the years,
this conference has been recognized as an excellent training environment for the topics selected
in the program covering a wide variety of subjects with great scientific relevance in the field. This
is accomplished by the inclusion of diverse outstanding faculty, permitting extensive discussions
and exchange of ideas. The faculty and participants have many opportunities to interact at the
formal sessions and during scheduled and non-scheduled social encounters. This serves to
stimulate young trainees in areas of research development, to foster interest in pediatric
nephrology as a career choice and develop international collaborations. In addition, this
conference brings together established investigators that benefit significantly from their collegial
discussions and interactions during and after the seminar. The support of the NIH through the R-
13 mechanism provides not only financial support but offers another level of prestige and incentive
towards research and discovery in the field of Pediatric Nephrology.

Public health relevance
Project Narrative The Miami Pediatric Nephrology Seminar is entering its 50th anniversary year as a sustaining landmark conference for the sub-specialty of Pediatric Nephrology as well as its many affiliates to be held March 15-17, 2024, in Miami Beach, Florida. The seminar is seen as a unique opportunity for pediatric and adult nephrologists, renal pathologists, neonatologists, pediatric urologists, transplant surgeons, nurses, nutritionists, and allied health professionals from all over the United States and the world. This is accomplished by the inclusion of diverse outstanding faculty, permitting extensive discussions and exchange of ideas and serves to stimulate young trainees in areas of research development, to foster interest in pediatric nephrology as a career choice and develop international collaborations.